Quorum Sensing Regulation of EHEC Virulence Genes

See continuation page 24 for project summary. Per NIH instructions, submit a one-page abstract of the
research plan for the entire extension period (3-5 years)
RELEVANCE (See instructions):
The goal of this project is to investigate how different host neurotransmitters impact the balance among
microbiota-pathogen-host interactions. We will assess how the stress hormones epinephrine and
norepinephrine have their impact on enterohemorrhagic E. coli (EHEC) virulence gene regulation
counteracted by an endocannabi noi d. We will also investigate how the microbiota alters the availability of
the active form of these neurotransmitters in the gut.

Public health relevance
Public Health Relevance Statement Project Narrative The goal of this project is to investigate how different host neurotransmitters impact the balance among microbiota-pathogen-host interactions. We will assess how the stress hormones epinephrine and norepinephrine have their impact on enterohemorrhagic E. coli (EHEC) virulence gene regulation counteracted by an endocannabinoid. We will also investigate how the microbiota alters the availability of the active form of these neurotransmitters in the gut.